The Impact of Donor Diabetes on Corneal Immune Cells and Graft Survival

Corneal transplantation is the most commonly performed allografting procedure in the world—nearly 40,000
cases in the United States and over 200,000 globally are performed each year. As surgical techniques, eye
banking procedures and prophylactic measures against graft rejection have improved, the field has also
become more sensitized to the quality of the donor tissue, including donor factors that can impact long-term
graft survival. In this regard, and in the context of the global `epidemic' of diabetes which affects over 10% of
the American population (over 30 million people), there are increasing reports that the diabetic status of donors
can adversely impact corneal graft survival. While the diabetic state in graft recipients, which is associated with
delayed healing and prolonged inflammation, has long been identified as a risk factor for transplant longevity,
the concept that a history of diabetes in the tissue donor can also impact graft survival is both novel and
potentially highly impactful from an eye banking and tissue selection standpoint. This would mean that
corneal transplant risk stratification would include the donor diabetic state in the decision algorithm for tissue
allocation. To investigate the potential role of the donor diabetic state on graft immunity, we began preliminary
studies in a mouse model of diabetes to assess how it would affect the resident immune cells of the cornea,
which could impact host sensitization and alloimmunity. Our preliminary data show that (1) there are more
matured corneal resident antigen-presenting cells (APC) in diabetic mice, (2) both penetrating and lamellar
(DSEK) allografts procured from diabetic donor mice have significantly worse survival than those procured
from non-diabetic donors, (3) hosts receiving diabetic tissue show heightened T helper-1 (Th1) immunity to
donor-derived antigens. Moreover, our preliminary data suggest that (4) glycemic control in diabetics
decreases MHC-II expression by corneal APC. Accordingly, we hypothesize that the diabetic state induces
an altered corneal microenvironment that alters the immune homeostasis of the cornea, inducing APC
maturation and regulatory T cell dysfyunction, that lead to heightened host sensitization and graft
rejection. To test this hypothesis, we will pursue three specific aims. In Aim 1, we will define the degree of
change in corneal APC functional phenotype in diabetic mice and assess the alloimmune response in hosts
receiving diabetic donor tissue (PK and DSEK). We will then investigate the mechanisms by which graft-
derived APC from diabetic donors impact host allosensitization (Aim 2) and regulatory T cell (Treg) dysfunction
(Aim 3). This grant, which represents a new area of investigation, is anchored in the core expertise of our lab,
which has studied corneal transplant immunity for more than 25 years. Knowledge gained from this grant holds
the potential to impact eye banking and tissue allocation as well as open new translational venues such as
manipulating donor tissue APC maturation/activation ex vivo, improving transplant outcomes and reducing the
risk of donor tissue shortages as a result of excluding all diabetic tissues.

Public health relevance
Corneal transplantation is the most common form of tissue grafting, and diabetes affects over 10% of the US population, accounting for over 34 million cases. Remarkably, while there is increasing data implicating a history of diabetes among tissue donors as a risk factor for subsequent transplant failure, there is little scientific insight into the mechanisms that underlie this association. This grant proposes to continue our ongoing investigations that suggest a strong link between the diabetic state and activation of resident immune cells in the tissue, a line of investigation that could potentially have major implications for eye banking and corneal transplantation.